High-throughput identification and characterization of conserved regulators of drug-induced plasticity using single-neuron resolution atlases of the complete Caenorhabditis elegans nervous system

Project Summary/Abstract
Chronic exposure to psychostimulants leads to maladaptive long-lasting molecular and
functional changes in the brain of vulnerable individuals that may contribute to
susceptibility to Substance Use Disorder (SUD). Despite significant advances in
understanding genetic and epigenetic factors that may underlie SUD, few effective
treatment options exist. In order to advance our knowledge to therapeutic avenues, we
need to overcome some of the existing technical and practical limitations of existing
models, including the inability to characterize drug-induced changes nervous-system-
wide with cellular resolution and the lack of in vivo high-throughput screening platforms
for putative regulators and therapeutic compounds. The nematode Caenorhabditis
elegans is a simple and well-characterized model organism that has led to many
fundamental discoveries in conserved biological mechanisms. The genetic amenability
and the compact nervous system allow us to conduct high-throughput screens and to
analyze the entire nervous system with single neuron resolution, respectively.
Combining advanced genetic, genomics, microscopy, and behavioral approaches, we
will generate comprehensive molecular (transcriptome and chromatin landscape),
behavioral, and neuronal activity atlases in response to acute vs. chronic exposure to
cocaine. Leveraging these atlases, we will use high-throughput screening approaches in
C. elegans to identify genetic regulators that underlie nervous-system-wide molecular
and functional changes as a result of drug exposure. Finally, the genetic amenability of
the C. elegans model allows us to causally examine the mechanistic roles of these
regulators in drug-induced plasticity with unprecedented locus and cellular specificity.
By establishing these approaches and platforms in the C. elegans model with cocaine,
we can investigate other classes of drugs in the future, and open up new avenues for
disease mechanism investigation and therapeutic identification for SUD.

Public health relevance
Project Narrative Chronic exposure to drugs such as psychostimulants produces long-lasting molecular and functional changes in the brain, which in vulnerable individuals result in behavioral changes that further predispose them to loss of control in their drug use and progression of Substance Use Disorder (SUD). These drugs produce remarkably similar behavioral outputs and act on similar molecular targets in the nervous system (brain equivalent) of the simple yet powerful model organism Caenorhabditis elegans. In this proposal, we leverage the capabilities for high-resolution, large-scale, and rapid genetic analysis of the entire nervous system in C. elegans to identify candidate regulators of long-lasting drug-induced changes and open up novel avenues of therapeutic interventions for SUD.